ORAL MALARIA VACCINE DEVELOPMENT INA P BERGHEI MODEL

Peptide carrier and recombinant DNA produced Plasmodium falciparum sporozoite subunit vaccines are being tested in clinical trials. These vaccines are designed to induce high titer protective antisporozoite antibodies. Efficacy of these vaccines remains to be established. Recent studies compared analogous peptide and recombinant subunit vaccines with sporozoite induced immunity in the P. berghei model. These studies showed that parenterally administered P. berghei subunit vaccines induce high titer sporozoite antibody which is partially protective at low sporozoite challenge doses. In contrast, sporozoite induced immunity, fully protective at 20 times the challenge, is mediated by cellular immunity. These studies are designed to examine the feasibility of immunizing mice against P. berghei sporozoites, a rodent malaria parasite, by oral vaccination. Vaccination of mice with an attenuated Salmonella strain harboring plasmids which direct the extracytoplasmic localization of the CS protein is expected to elicit not only antibody but also cell mediated immune responses. The P. berghei CS gene will be fused to the gene encoding the B subunit of the heat labile enterotoxin of E. coli (LTB) at various locations and the fusion protein tested for immunogenicity. If these studies are successful, analogous oral malaria vaccines could be developed for humans.